Identification of Computational Phenotypes in Pediatric Status Asthmaticus and Determination of Treatment Effect

Project Summary
Pediatric asthma is a growing epidemic associated with significant burden to the healthcare
system which lacks individualized treatment approaches. Although standard treatments for
pediatric status asthmaticus are adequate for most patients, a subset do not respond quickly.
These children are at risk for severe physiologic derangements including hypercarbia,
hypoxemia, cardiac dysfunction, and death. Adjunctive asthma therapies can potentially provide
benefit to children with status asthmaticus; however, there is limited evidence regarding their
efficacy. Not only are these adjunctive therapies potentially ineffective, but many are associated
with severe side effects. My central hypothesis is that children presenting to the hospital with
status asthmaticus can be effectively subdivided into distinct clinical phenotypes that exhibit
heterogeneous treatment effects. I propose to test this hypothesis by (1) identifying distinct
clinical phenotypes in children presenting to the hospital with status asthmaticus, (2) validating
the clinical phenotypes of status asthmaticus in other pediatric institutions, and (3) comparing
effects of the adjunctive asthma treatments magnesium and aminophylline between clinical
phenotypes. With the preliminary data generated, new skills obtained, and expertise gained
through this K01 award, I plan to construct a robust computational phenotype for pediatric
asthma, identify the patients most likely to have improved clinical outcomes with specific asthma
therapeutics, and decrease the health burden of children with status asthmaticus in a future R01
study.
During the award period, I will continue to conduct research under the primary mentorship of Dr.
Eneida Mendonca, who is a pediatric critical care physician and established health informatics
researcher, as well as the co-mentors and advisors outlined in the career development plan. I
will obtain additional training in artificial intelligence and machine learning methods such as
unsupervised clustering methods, health informatics and information systems, and comparative
effectiveness research methods through both formal coursework as well as established
institutional programs. With the preliminary phenotyping data generated by this study, the
experience gained using health informatics and machine learning methods, and a knowledge
foundation of comparative effectiveness research methods, I will be well-positioned to transition
to research-independence.

Public health relevance
Project Narrative Status asthmaticus is a life-threatening condition in the pediatric critical-care population that can be difficult to treat, and while there are a host of proposed therapies, there is little evidence regarding the optimal treatment strategy. We propose a novel approach using unsupervised machine learning methods to identify and validate distinct clinical phenotypes of pediatric patients with status asthmaticus, and to test the effects of magnesium and aminophylline between the identified phenotypes. The goal of this line of research is to establish precision medicine treatment approaches to improve the clinical outcomes for these patients.